Genetic Epidemiology of Caffeine and Cognitive Decline

PROJECT SUMMARY
Age-associated cognitive decline is an important human condition that varies in extent among individuals. This
variation likely arises from a complex interplay of genetic and environmental factors. Caffeine is the most
commonly ingested behaviorally active substance in the world, and a growing body of literature points to the
premise that caffeine may provide a safe, effective, readily available, and inexpensive therapeutic agent
against cognitive decline. However, factors that contribute to variation in caffeine metabolism may interact with
caffeine intake and modify its association with cognitive decline. Furthermore, caffeine targets genes and
pathways potentially impacting cognitive decline and thus an opportunity to advancing our understanding of
this condition may be missed if variation in caffeine metabolism is left unaccounted for.
Dr. Cornelis proposes a training and research plan that will contribute to her goal to become an independent
investigator of systems epidemiology of nutrition and cognitive decline. To acquire training in i) cognitive
function assessment ii) epidemiology of cognitive decline and iii) neuropathological aspects of cognitive decline
and Alzheimer's disease, she works closely with a team of internationally recognized mentors from two highly
reputable institutes committed to aging research and engages in training activities including coursework, one-
on-one and small group sessions, seminars and conferences, observation and hands-on practicum.
She will apply her training to the first comprehensive and highly efficient analysis of the joint effects of genetics
and caffeine on cognitive decline. Composite indices of caffeine metabolic rate and caffeine exposure will be
used in an epidemiological meta-analytical framework to examine genecaffeine intake interactions and
cognitive decline and to discover novel loci for this condition by modeling SNPcaffeine exposure interactions
on a genome-wide scale.
Dr. Cornelis's research will provide critical insights into the role that caffeine potentially plays in slowing
cognitive decline and has potential to uncover novel biological pathways underlying this condition. Results of
this work should foster new lines of investigation for cognitive impairment and for developing novel behavioral
and pharmacological avenues for safe and effective treatment and prevention. Moreover, the experience and
knowledge obtained from the completion of Dr. Cornelis's training and research plan will allow her to obtain
R01 funding to acquire additional systems-level data for a more detailed mechanistic view of how caffeine or
other dietary factors impact cognitive decline.
This Administrative Supplement will allow Dr. Cornelis to complete her K01 training and research that was
disrupted by COVID-19 shutdowns. Limited availability of cohorts and research staff for nutrition data curation
required research revisions and more time. COVID-19 also disrupted the neuropathology training Dr. Cornelis
needed to complete her K01 analyses in a timely manner.

Public health relevance
PROJECT NARRATIVE Dr. Marilyn Cornelis will engage in a training program that will contribute to her goal to become an independent investigator of systems epidemiology of nutrition and cognitive decline. Using novel indices of caffeine metabolism and exposure, she proposes the first comprehensive and efficient analysis of the joint effects of genetics and caffeine on cognitive decline in a population setting. This research will provide critical insights into the role that caffeine potentially plays in slowing cognitive decline and has potential to uncover novel biological pathways underlying this condition.